Assessment of Zoonotic Risk of Emerging Infections in Companion Animals

Project Summary/Abstract
This project evaluates the zoonotic implications of two important possible pathogens of companion
animals: E. coli and coronaviruses. E. coli is the most common pathogen tested for antibiotic susceptibility in
veterinary diagnostic labs. It is also one of the most concerning for multi-drug resistance; several isolates
captured thus far in Vet-LIRN active surveillance are predicted to be pan-resistant to all drugs used in human
or animal medicine. Our group has published the first animal host specific E. coli virulence database
compatible with tools that can mine whole genome sequencing data. We now propose a comparative
evolutionary genomic study to assess the potential of E. coli in dogs to encode novel resistance mechanisms
and cause disease in humans. The data will be explored employing the latest developments in bacterial pan-
genomic analysis, as well as bacterial GWAS. Such analysis will reveal if there are E. coli loci adapted to dogs,
whether such loci have the functional character suggestive of pathogenic potential, and whether dogs may be
a reservoir of potential pathogenesis or antibiotic resistance.
The present outbreak of coronavirus disease caused by SARS-CoV-2 (COVID-19) is the third
documented spillover of an animal coronavirus to humans to have resulted in a major epidemic, within the past
two decades. Characterizing the species diversity of coronaviruses from companion animals, represents an
important necessary step towards improving our understanding of virus–host interactions and to enhance our
preparedness for future outbreaks. We will undertake this characterization in three different host species –
horses, cats, and dogs – making use of an extensive set of time series samples (respiratory and feces) that
comprise the AHDC’s collection. Sequences of coronavirus genomes will be acquired using two approaches:
RNAseq of the respiratory virome and multiplexed amplicon approaches of both respiratory and feces samples;
the former will allow us to identify the coronavirus species repertoire of each host, including the identification of
any new coronavirus species, the latter will provide the ability to explore aspects of diversity in detail, within
and between hosts. Comparative evolutionary genomic analyses of the data will inform on a wide variety of
issues related to their zoonotic potential, including for example: (1) Which coronavirus species are more prone
to inter-host transmission and is there a directionality to that transmission? (2) Are their host reservoirs for any
of the virus species? (3) Which have a history of recombination? (4) Which have a history of molecular
adaptation and what viral proteins does that involve?
Our final aim is to provide eight other Vet-LIRN sequencing laboratories with the reagents and training
to be able to independently sequence and analyze bacterial and viral genomes, including SARS-CoV-2. All
three Aims of this project directly support the mission of the FDA to ensure the safety of our nation's food
supply and protect public health.

Public health relevance
Project Narrative In support of the FDA CVM antibiotic stewardship plan, our group has actively supported the technological capability and capacity of Vet-LIRN laboratories to perform genomic techniques for real-time antimicrobial resistance surveillance in a consistent and reliable manner. Now that a significant amount of data for E. coli in dogs is available and has brought attention to serious concerns, we propose to perform a comparative genomics study designed to assess the potential of E. coli in dogs to carry loci that might confer resistance to antibiotics and/or cause disease in people. We will also characterize the repertoire of coronaviruses in companion animals, conduct evolutionary genetic analyses that will provide an assessment of their potential risks for zoonotic transmission, and provide training in viral whole genome sequencing to other network laboratories.